Non Invasive Measurements of Muscle Microstructures Assessed by Diffusion Tensor Imaging

PROJECT SUMMARY
Skeletal muscle exemplifies structure-function relationships in biology. The organization of sarcomeres follow
hierarchical ordering to form long contractile cells, bundled in extra-cellular matrix, to form larger fascicles and
ultimately whole muscles. The tight relationship between structure and function allows muscle performance
(and disease) to be inferred from its microstructure. For example, fiber area is directly related to isometric force
production in muscle. With injury, microstructural changes in muscle fiber area (size), fibrosis (accumulation of
extracellular matrix), membrane damage (permeability), and inflammation (edema) are observed, and impair
muscle function. Muscle biopsy, followed by microscopic examination of the tissue (histology), is the gold
standard to diagnose and monitor muscle health and disease. This tool is invasive, requiring a large bore
needle and tissue removal under sterile conditions, which makes it painful and costly. Therefore, biopsy is not
conducive to serial monitoring of muscle health. It is also semi-quantitative, and often difficult to extrapolate to
the entire muscle, limiting its scientific and clinical value. For these reasons, there is a need for noninvasive
assessment of muscle microstructure, which would facilitate the quantitative examination of muscle injury over
time. Magnetic resonance imaging (MRI) has been used to noninvasively quantify changes in volume, fat
distribution, and water content in muscle. Diffusion MRI (dMRI) is a version of MRI that measures anisotropic
diffusion of water, which is related to tissue microstructure. Many studies have used dMRI to measure
restricted diffusion in injured skeletal muscle and have theorized how microstructure relates to diffusion.
However, these relationships are not explicitly tested nor carefully validated because the necessary
experiments are complicated and difficult to rigorously control. To address this gap in knowledge, the purpose
of this proposal is to define the relationship between restricted diffusion and muscle microstructure assessed
with classic and innovative new dMRI techniques. Our central hypothesis is that dMRI measurements can be
optimized to detect small but clinically relevant changes in muscle microstructure. Aim #1 will investigate a new
dMRI pulse sequence and analysis technique that has enhanced sensitivity to muscle microstructure using
previously established computer simulation and 3D precision engineered models. In Aim #2, we will utilize
animal models of clinically meaningful muscle injuries to evaluate sensitivity of common, less common, and
novel dMRI pulse sequences to detecting microstructural differences between models. In Aim #3, we will utilize
a multiparametric MRI protocol to assess diagnostic, prognostic, and functional changes associated with a
clinically relevant animal model of muscular dystrophy. These experiments will elucidate the relationships
between microstructure and diffusion in muscle. The long-term goal is to non-invasively, serially quantify
muscle microstructure. This approach is innovative in that it combines state-of-the art imaging, simulation,
nanofabrication, and physiology approaches to develop a clinically meaningful measurement tool.

Public health relevance
PROJECT NARRATIVE Skeletal muscle is important for function, metabolism, and cardiovascular health, and therefore, muscle injury and disease adversely affect quality of life and healthcare costs. Muscle biopsy is the gold standard for diagnosis and monitoring muscle disease and recovery, but is prone to sampling errors and invasive. Here we propose novel diffusion MRI experiments to accurately and non-invasively assess muscle health and pathology.